Functional and Mechanistic Dissection of GPCR Endosomal Signaling Dynamics

Abstract
G protein-coupled receptors (GPCRs), which compose the largest class of drug targets, are critical signaling
proteins that translate extracellular stimuli to mediate human physiology. As such, understanding GPCR
signaling cascades will provide insight into the molecular mechanisms underlying these complex physiological
processes, their perturbation in disease, and inform our ability to design more efficient therapeutics. In recent
years, my lab and others have made a paradigm-shifting discovery that GPCRs can be activated after drug-
induced internalization from the plasma membrane into endosomal compartments. However, one essential
variable that remains unexplored is how the temporal dynamics of GPCR endosomal cAMP activity impact
downstream signaling. In the current proposal, I will dissect the influence of the duration of GPCR activation in
endosomes on downstream signaling, identify novel protein complexes that regulate receptor spatiotemporal
signaling dynamics, and apply this knowledge to a physiologically relevant system—hippocampal neurons. By
combining functional genomics, proteomics, and optogenetics, this proposal aims to provide a comprehensive
understanding of how the temporal dynamics of GPCR signaling in endosomes regulates biological functions.
This work is essential to comprehending the mechanisms of GPCR signaling and identifying novel signaling
pathways, providing new targets for pharmacologic therapies.

Public health relevance
G protein-coupled receptors (GPCRs) are expressed widely throughout the body and mediate numerous physiologies and pathophysiologies. Recently, GPCRs were shown to signal from internal membranes and to give rise to location-specific downstream cellular responses; however, if and how the dynamics of signaling from these intracellular compartments may modulate responsiveness has not been addressed. The proposed experiments will investigate this aspect and thus are poised to provide novel insights into how these receptors transduce their myriad of downstream effects in the cell and identify new potential targets for pharmacological intervention.